Single domain antibodies for diagnosis and treatment of synucleinopathies

Abstract
Immunotherapies targeting aggregates of amyloid-β (Aβ), tau and α-synuclein (αsyn) are the most
common experimental approach for diseases characterized by such depositions. Most of these potential
therapies are whole antibodies. Antibody fragments have certain advantages over antibodies but their
diagnostic and therapeutic potential has not been well explored. Five anti-αsyn IgG antibodies and one αsyn
vaccine are in Phase 1-2 clinical trials, and one Aβ antibody recently showed clinical benefit in a Phase 3 trial,
which strongly supports this therapeutic approach. Regarding antibody fragments, several anti-αsyn single
chain variable fragments (scFvs) are effective in culture and in vivo, and two anti-αsyn single domain
antibodies (sdAbs) have been characterized in a binding assay but their therapeutic efficacy or diagnostic
imaging potential have not been reported. SdAbs have several advantages over scFvs, including higher
affinity, binding to cryptic epitopes and simpler engineering. They are also more suitable for gene therapy
because of uncomplicated expression and predictable protein folding, given their single domain, resulting in
high solubility.
We have developed 58 anti-αsyn sdAb clones with unique binding regions from a screen of phage
display libraries generated from B-cells of a llama immunized with αsyn. Three aims are proposed to clarify
their potential to detect and clear αsyn in vivo. Aim 1 will determine the in vivo imaging potential of sdAbs
targeting αsyn. Aim 2 will clarify αsyn clearance potential and mechanism of action of sdAbs targeting αsyn,
and Aim 3 will explore the feasibility of sdAb gene therapy targeting αsyn.
Preliminary findings indicate that the sdAbs: 1) recognize various forms of αsyn with high affinity; 2)
clear αsyn and prevent its toxicity in culture models; 3) clear αsyn from brain interstitial fluid in αsyn mice; 4)
bind to αsyn in the brain of αsyn mice after intravenous injection with in vivo brain signal that correlates well
with αsyn brain burden; 5) clear αsyn from the brain after intravenous injection of sdAb with improved
clearance by its PROTAC derivative, and; 6) clear αsyn from the brain after intravenous sdAb gene therapy. It
is hypothesized that the small size of the sdAbs will provide diagnostic and therapeutic benefits over whole
antibodies, primarily because of greater access into the brain and to the target, proper folding for gene therapy,
and to some extent due to their binding to novel epitopes that the larger antibodies cannot access.
Overall, the proposed studies are likely to aid in clarifying αsyn pathogenesis, decipher the mechanism
of action of the sdAbs, and identify promising diagnostic and therapeutic sdAbs for clinical trials on
synucleinopathies such as Lewy Body Dementia, Parkinson's disease, Alzheimer's disease with Lewy Bodies,
and Multiple System Atrophy.

Public health relevance
Narrative The purpose of this project is to assess the diagnostic imaging potential of novel small antibody fragments and their efficacy as potential therapies for synucleinopathies such as Lewy Body Dementia, Parkinson's disease, Alzheimer's disease with Lewy Bodies, and Multiple System Atrophy. The proposed studies may also enhance our understanding of α-synuclein pathogenesis. Hence, this research is very relevant to public health.